Addressing Disparities in Polygenic Risk Score for Coronary Heart Diseases in Diverse Populations

PROJECT SUMMARY/ABSTRACT
Coronary heart disease (CHD) remains a leading cause of death worldwide, and accurate risk prediction is crucial
for early intervention. While clinical risk scores (CRS) based on traditional risk factors are commonly used,
polygenic risk scores (PRS) have emerged as a promising tool, particularly when combined with CRS. However,
current CHD PRSs have limited predictive value, especially for populations with diverse ancestries. Additionally,
CRS fails to account for environmental and social factors that contribute to CHD disparities in minority groups.
To achieve health equity and improve CHD health for all, it is crucial to tailor CHD risk prediction approaches
to individuals based on their genetic background, susceptibility to traditional risk factors, as well as their social
and environmental context. Dr. Tcheandjieu's career goal is to leverage these factors to develop an inclusive risk
prediction strategy that mitigates disparities. In the current project, she will focus on understanding the genetic
architecture of CHD across populations. She hypothesizes that the limited predictive value of current CHD PRS
in diverse populations is due to the Eurocentric bias in their development, the exclusion of low-frequency genetic
variants, and inadequate representation of the genetic contribution of CHD risk factors, especially since the
prevalence of CHD risk factors varies across populations. To test these hypotheses, she will analyze genetic data
from 2.1 million individuals with European, African, Indigenous American, and Asian ancestries from large
biobanks. In Aim 1, she will explore population-specific differences in haplotype structures, allele frequencies,
and effect sizes of variants in CHD and PRS. In Aim 2, she will study the association between CHD and rare
variants within each ancestry, quantify CHD heritability due to rare variants, and assess their PRS predictive
value. In Aim 3, Dr. Tcheandjieu will develop population-specific CHD PRSs with enhanced predictive value by
incorporating the genetic risk for CHD and its risk factors, considering variations between ancestries and
enriching the PRS with rare variants. To achieve these aims and strive toward her career goal, Dr. Tcheandjieu
will strengthen her knowledge with training in statistical and population genetics, functional genomics, and
cardiovascular social epidemiology. Dr. Tcheandjieu will be mentored by a team of scientists with extensive
experience and expertise in various aspects of her proposed research and training. Additionally, The Gladstone
Institutes and the University of California, San Francisco are world-leading biomedical research centers. Dr.
Tcheandjieu will take advantage of the rich resources within these research environments to complete the
program. Overall, the research, training, and institutional environment described in this proposal will aid Dr.
Tcheandjieu in her long-term career goals of (1) addressing disparities of CHD susceptibility across diverse
populations and (2) becoming a successful independent investigator. Overall, the proposed research has
significant potential to address the limited applicability of current PRS to diverse populations and develop novel
and innovative CHD PRSs that improve risk prediction in diverse populations, reducing health disparities.

Public health relevance
PROJECT NARRATIVE Coronary heart disease (CHD) is a leading cause of death globally, and accurate risk prediction is vital for early intervention. However, current polygenic risk scores (PRS) for CHD have limited predictive value, particularly for populations with diverse ancestries, due to underrepresentation in genomic studies. Exploiting multiple recently developed increasingly diverse biobanks with 2.1 million individuals, Dr. Tcheandjieu aims to address these disparities by developing population-specific CHD PRSs, tailoring risk prediction approaches to individuals based on their genetic background, susceptibility to traditional risk factors, and social and environmental context.